Genetic Models Core

PROJECT SUMMARY/ABSTRACT – CORE B
Project Leaders supported by the Center for Musculoskeletal Disease Research (CMDR) and other members
of the Center will require the generation of new genetically modified mice to accomplish the goals of their
proposed studies. The Genetic Models Core established at University of Arkansas for Medical Sciences (UAMS)
during Phase 1 of this COBRE will serve these needs. This core was an outgrowth of an existing transgenic
mouse core with a strong record of producing transgenic mice. Expansion of this facility during Phase 1, made
possible by COBRE support, allowed the core to effectively serve Project Leaders, other members of the CMDR,
and investigators at affiliated institutions and across Arkansas. For Phase 2, we propose to build on this success
by maintaining the high-quality services provided by the Core and working to develop new services based on
cutting-edge technologies. In Aim 1, we propose to maintain the Genetic Models Core for Project Leaders and
other CMDR members by implementing a successful business plan to operate a facility dedicated to the
generation, use, and maintenance of genetically modified mice. In Aim 2, we will provide genetic-model services
to Project Leaders and other CMDR members. Generation services will include the design and creation of
transgenic or gene-edited mice by pronuclear injection. Maintenance services will include sperm
cryopreservation, in vitro fertilization, and strain rederivation. New approaches will be developed and existing
approaches will be optimized in collaboration with Project Leaders and other CMDR members. Core personnel
will continuously update gene-editing tools for mouse modification via evaluation of current literature and
attendance at workshops and meetings. In Aim 3, we propose to continue to provide training and education
related to the use of genetic models. Project Leaders and other users will be trained to efficiently and accurately
produce experimental cohorts of genetically modified mice, and we will educate users on potential problems that
are often encountered with the use of such models. Core personnel will also educate the research communities
at UAMS and other campuses in Arkansas about the services and technologies available through the Genetic
Models Core. The scientific theme of the CMDR is that identification of molecular contributors to musculoskeletal
dysfunction and disease will guide development of effective therapies. The Genetic Models Core is consistent
with this theme in that it will allow Project Leaders to rapidly and efficiently test the roles of specific molecular
changes in pathological processes that affect the skeleton or in which the skeleton plays a major role.